Modulating Low-Frequency Cortical Population Dynamics to Augment Motor Function After Stroke

PROJECT SUMMARY
Stroke is the leading cause of motor disability in the United States, with approximately 700,000 new cases per
year. Impaired hand and finger control are a leading cause of such disability. Despite advances in task-
specific training for the upper limb, a large number of stroke patients do not regain full function of their hand;
novel treatment methods are urgently required. We propose to use a systems neuroscience and `neural
engineering' framework that captures the dynamic interactions between neurons and the distributed motor
network to both characterize and develop novel neurophysiological based neuromodulation approaches to
enhance motor function. Studies in healthy animals support a framework for dynamic interactions between
local and distant areas through transient oscillations. Oscillations are defined by a frequency bandwidth, e.g.
motor areas are known to have task-related low-frequency oscillations (0.5-4 Hz). How the recovery process
affects neural activity and oscillatory dynamics in primates preforming dexterous tasks remains unknown?
Our recent studies in rats (Ramanathan et al., Nature Medicine 2018; Lemke et al., Nature Neuroscience,
2019) demonstrated that population dynamics linked to low-frequency oscillatory activity (0.5-4Hz “LFO”) are
essential for movement control, track spontaneous recovery and can serve as a target for modulation using
electrical stimulation. More specifically, cortical stimulation was found to both boost LFO power and augment
motor function. Essential translational steps involve testing whether this approach also works for gyrated
brains during the performance of dexterous tasks.
This proposal aims to use in vivo electrophysiological methods to model the network dynamics of recovery.
The underlying hypothesis is that synchronous LFO spike-field interactions in the perilesional cortex are
important for recovery and its modulation can augment dexterous motor function. Importantly, our preliminary
data provides strong support for our proposed research goals; we have found that low-frequency oscillatory
dynamics drive coordination of sensory and motor areas during recovery and that artificial low-frequency
electrical stimulation can boost dexterous function during recovery.
Completion of these aims will provide critical information for designing therapeutic approaches that specifically
target perilesional oscillatory activity with low frequency electrical stimulation. Focusing on targeted
neuromodulation of such dynamic network interactions represents a new direction that could transform our
ability to augment upper extremity function following stroke.

Public health relevance
PROJECT NARRATIVE Stroke is the leading cause of disability in the United States, leaving a substantial number of survivors with permanent weakness. Neuromodulation of sensorimotor areas using physiologically targeted low-frequency stimulation is an innovative new direction to facilitate recovery of motor function. Our proposal seeks to optimize stimulation parameters as well as to develop electrophysiological makers of network function that delineate underlying mechanisms of action.